Mechanisms addressing the causal relationships of sleep, circadian rhythms, and cardiometabolic health

Modern lifestyles have led to short sleep and misalignment of behaviors to the endogenous circadian clock,
which is governed by the light-dark cycle. The resulting deleterious effects on sleep quality and circadian rhythms
have been associated with a plethora of chronic diseases that afflict a large portion of the population. Specifically,
short sleep duration, poor quality sleep/sleep disorders, and circadian misalignment have been associated with
an increased risk of obesity and cardiovascular disease. However, the causality of these associations and their
underlying mechanisms have yet to be fully uncovered. In attempting to uncover the causal impact of insufficient
sleep on obesity, our lab has shown that acute sleep restriction upregulates neuronal reward networks implicated
in hedonic food consumption and results in higher intake of energy, particularly from fat, relative to adequate
sleep. Others have also shown that these sleep manipulations drive late-night eating, which may then cause
circadian misalignment. However, acute sleep restriction (<4 h of sleep/night for 5 nights) is not a typical behavior
and we are now testing the impact of longer, milder forms of sleep restriction as well as prolonged circadian
misalignment, on energy balance and cardiovascular disease risk. The main objective of this proposed research
program is to elucidate the pathways by which sleep patterns and alignment of lifestyle behaviors, namely food
consumption, activity, and sleep, to one another influence obesity and cardiovascular disease risk. We propose
mechanistic clinical intervention studies in men and women that manipulate sleep and circadian rhythms as
exposures on cardiometabolic risk factors. These randomized controlled interventions will include outcomes such
as energy balance (measurements of food intake, energy expenditure, and body composition) and
cardiovascular disease risk factors (cellular and systemic inflammation, immune function, glucose regulation,
blood pressure). Men and women will be enrolled in equal numbers to assess whether the pathways that related
poor sleep and circadian misalignment to cardiometabolic risk differ by sex. We plan to use the research flexibility
afforded by this grant mechanism to expand collaborations with investigators in related and complementary fields
of research, resulting in sharing of techniques and research paradigms between laboratories, train fellows and
future investigators in the fields of sleep, circadian rhythms, and cardiometabolic health, and promote awareness
of the importance of sleep and alignment of lifestyle behaviors to circadian clocks for optimal health.

Public health relevance
Sleep duration and quality are related to obesity and cardiovascular diseases. However, how poor sleep influences energy balance (intake vs. expenditure) and whether the causality of the relation exists in the opposite direction (energy balance and cardiometabolic disorders affect sleep) remain unclear. This research program will elucidate the bi-directional relations between sleep, energy balance, and cardiometabolic disorders.